Humanity Unlocking Biomaterials (HUB) Coordinating Center

Biomaterial technologies have the potential to greatly impact human health by addressing various
diseases. Yet, their full benefits remain untapped due to the disconnectedness among academic
researchers and limited engagement with emerging disciplines. To address this, we propose the
establishment of the Humanity Unlocking Biomaterials (HUB) as an NIBIB Biomaterials Network
Technology Development Coordinating Center. The HUB will address the limitations to clinical
translation and commercialization of biomaterials technologies by creating a collaborative network
and providing resources and roadmaps to the network for faster dissemination, technology
transfer, and education. The specific aims include nucleating a broad network of biomaterials
researchers via annual meetings, facilitating collaboration and coordination through virtual
infrastructure, promoting a paradigm change that leverages computational modeling and
simulation, disseminating advances and educational materials, engaging the network, and
providing funding, via NIBIB Opportunity Funds, to accelerate the development and translation of
biomaterials. Led by a team of distinguished scientists and engineers, the HUB will revolutionize
biomaterials translation, promoting cross-disciplinary collaboration and innovation to advance
cutting-edge technologies for clinical applications.

Public health relevance
Project Narrative The proposed work aims to establish the Humanity Unlocking Biomaterials (HUB), a coordinating center that addresses the disconnectedness among biomaterials researchers and emerging disciplines, such as computational modeling and artificial intelligence, to unlock the full potential of biomaterials-based technologies. By creating a broad community, providing accessible resources and funding opportunities, and fostering cross-disciplinary collaboration, the HUB seeks to revolutionize biomaterials translation and produce innovative technologies for biomedical applications. The HUB aims to significantly improve human health and save lives impacted by various diseases through this initiative via expansion of translation of novel biomaterials-based technologies